Examining co-production as an implemntation strategy for autism early intervention delivered in Part C service systems

PROJECT SUMMARY/ABSTRACT
The purpose of this K23 Career Development Award is to support the applicant in acquiring the knowledge and
skills needed for an independent research career as an implementation scientist who evaluates strategies that
enhance the impact of early intervention for children with Autism Spectrum Disorder (ASD) when delivered in
diverse service systems. It will achieve this by complementing the candidate’s background in community
engaged research with expert mentorship in intervention fidelity and adaptation, clinical decision making,
clinical trial design and evaluation, and [autism service inequities among underrepresented children].
Persistent disparities accessing early intervention compromise the quality of life of autistic children and their
families and can be addressed by translating evidence-based treatments, such parent-mediated interventions
(PMIs), into service systems that are an access point to care for young children. Although translation efforts
are under way, high attrition has compromised the impact of PMIs when delivered win marginalized
communities. This gap may reflect an emphasis on implementing PMIs in a manner that maintains fidelity while
also at times conflicting with the complex needs of underrepresented families that inevitably arise in PMI. This
K23 proposal will address this gap by evaluating co-production, or the balance between fidelity and family-
centered care, within an evidence-based PMI for ASD, Project ImPACT, delivered in a state-funded Early
Intervention system. Mixed-methods findings from the first research aim will be used by key stakeholders to
develop and evaluate an implementation strategy that targets ideal co-production to enhance caregiver
engagement within Project ImPACT. Under the primary mentorship of Lawrence Scahill, Ph.D., an expert in
clinical trials for ASD, and co-mentorship from Aubyn Stahmer, Ph.D., Chris Sheldrick, Ph.D., [and Jennifer
Singh, PhD.], the applicant will pursue training in: 1) early intervention fidelity and adaptation; 2) clinical and
shared decision making; 3) the design and execution of clinical trials; and [4) cultural diversity and systemic
inequities]. Training in these areas will enhance the applicant’s pursuit of the following research aims: 1)
Evaluate co-production within Project ImPACT; 2) Develop an implementation strategy that targets ideal co-
production within Project ImPACT by teaching the balance of fidelity and family-centered care; and 3) Conduct
a pilot randomized trial to assess the feasibility of evaluating Project ImPACT training when paired with the co-
production implementation strategy (Project ImPACT-C) in comparison to Project ImPACT training as usual
(Project ImPACT-TAU). This proposal is aligned with NIMH’s strategic objective [4.3a to adapt evidence-based
intervention to account for moderators, including social determinants of health, that impact effectiveness
among underrepresented groups]. Further, the strong training and research plans embedded within this K23
proposal will effectively position the applicant for an independent research career evaluating strategies that
enhance the service outcomes of ASD interventions when implemented within diverse service systems.

Public health relevance
NARRATIVE The proposed research will develop and evaluate an implementation strategy that targets the balance between intervention fidelity and flexibility (i.e., co-production) in order to enhance caregiver engagement within a parent-mediated intervention (PMI) for Autism Spectrum Disorder (ASD) when delivered in a state-funded Early Intervention system. This is a critical need given high attrition when PMIs have been delivered in diverse community settings, which may reflect an emphasis on implementing and adapting PMIs in a manner that maintains fidelity while also conflicting with the complex needs of underrepresented families. This proposal and my long-term goals are aligned with NIMH’s objective [4.3a to adapt evidence-based models to account for moderators, including social determinants of health, that impact intervention effectiveness among underrepresented groups], as this project will develop and provide evidence on the feasibility of an implementation strategy aimed at enhancing caregiver engagement by blancing fidelity to an evidence-based PMI with the needs and priorities of caregivers who have been historically underrepresented in ASD early intervention research.